Stress management and vaccine response among women at risk for breast cancer

DESCRIPTION (provided by applicant): Cancer vaccines are emerging as important tools for cancer treatment and prevention. Unfortunately, the cohorts that ultimately will benefit most from the vaccines, those at elevated risk for cancer, are likely to be stressed. Chronic stress can impair immune function, including immune response to vaccines. An inadequate response to vaccines can weaken their protective effect. Women at elevated risk for breast cancer can experience significant levels of distress and have associated immune function decrements. Interventions to treat distress-related immune decrements among these women are needed because these women will be among the first candidates for breast cancer vaccines. In theory, stress-management interventions should improve immune function and response to vaccines;however, the findings to date are mixed. The proposed investigation will conduct an exploratory randomized clinical trial to collect preliminary data on the efficacy of a cognitive behavioral stress management (CBSM) group intervention among women who are at elevated risk for breast cancer because of family history and who are reporting elevated levels of distress. Study outcomes will include antibody and cellular immune response to hepatitis A vaccine and self-reported distress. PUBLIC HEALTH RELEVANCE: The present basic biobehavioral research proposal will investigate the interaction between psychosocial and biological mechanisms. In particular, the present study will collect pilot data for examining how reducing psychological stress may improve immune response to vaccines among women at risk for breast cancer. The goal of this research is ultimately to support using stress management intervention to improve immune response to cancer vaccines among those at risk for cancer.

Public health relevance
PROJECT NARRATIVE The present basic biobehavioral research proposal will investigate the interaction between psychosocial and biological mechanisms. In particular, the present study will collect pilot data for examining how reducing psychological stress may improve immune response to vaccines among women at risk for breast cancer. The goal of this research is ultimately to support using stress management intervention to improve immune response to cancer vaccines among those at risk for cancer.